Genetic Control of the SYK Tyrosine-protein Kinase in Allergy

SUMMARY
Allergic diseases represent a major public health burden characterized as an epidemic that involves the
interplay between genetic factors and environmental exposures. Allergens are one of the many multiple
triggers that produce IgE and cause inflammation of the airways, two crucial components of allergic disorders,
including atopic asthma. Spleen associated tyrosine kinase (aka tyrosine-protein kinase SYK) is critically
involved in the earliest steps of signaling reaction following aggregation of IgE/FceRI on the basophil/mast
cell surface after re-exposure to the same environmental substance (allergen). There is a considerable body
of evidence and a consistent set of observations, based on cellular functions and clinical associations,
highlighting the deeper relevance of SYK to the IgE-mediated reaction in humans. In addition, we have
demonstrated that basophil traits, such as SYK expression and IgE-mediated histamine release, can serve
as biomarkers for predicting the clinical efficacy of omalizumab in allergic diseases like asthma. However,
little is known about the genetic regulation of SYK, which is crucial in determining how IgE-dependent allergy
disorders manifest. We confirmed that the expression levels of SYK and histamine release in human basophils
were correlated with single nucleotide polymorphisms (SNPs) in the promoter of the SYK gene. Exploration
of cis-expression quantitative trait loci (cis-eQTL) discovered a genomic region encompassing the SYK
transcription start site (TSS), and it contained multiple variants with a high potential for transcriptional
regulation. We hypothesize that genetic factors interact with specific local cell/tissue environments to modify
either SYK expression or its function; therefore defining a unique molecular phenotype of human basophils,
which can serve as biomarkers for clinical efficacy of anti-IgE therapy as well as being potential drug targets
for novel therapeutics. This application's specific aims are to: (1) determine the genetic regulation of SYK
transcriptional activity and function; (2) identify common haplotypes that influence SYK expression and
function in individuals of European and African ancestry; and (3) compare transcriptome gene signatures
among IgE-bearing cell types. Results from these studies will provide strong motivation to explore the larger
impact of their influences on atopic disorders.

Public health relevance
NARRATIVE The IgE-mediated reactions in allergic diseases are greatly influenced by SYK tyrosine-protein kinase. We have discovered genetic polymorphisms in the SYK gene that are associated with atopy, SYK expression levels, and basophil function. We will determine the genetic regulation of SYK expression and function that affects the phenotypic traits of human basophils in allergies.